The effects of cART and HIV-1 infection on neural circuitry

ABSTRACT
A significant proportion of individuals receiving antiretroviral therapy (ART) for HIV-1 infection develop cognitive
deficits. This may be due solely to the HIV-1 infection; however, this may also indicate that prolonged ART itself
may contribute to the impairments, particularly in the context of HIV-1 infection. The latter possibility is of
particular concern given that a growing number of uninfected individuals use antiretrovirals (ARVs) as pre-
exposure prophylaxis (PrEP). The brain circuitry that may be affected by prolonged treatment with ARVs or by
ARVs in the context of HIV-1 infection is unknown.
We propose to apply our recently developed array of new tools for constructing, comparing, and analyzing 3D
whole-brain maps of neuronal activation in the mouse brain to reveal the critical neural circuitry affected by ARVs,
HIV-1 infection, and their combination. Our hypothesis is that 3D patterns of neuronal activation in animals
exposed to ARVs, HIV-1, and ARV/HIV-1 and involved in challenging behavioral tasks can both reveal the
crucial circuitry defining these effects and serve as unique signatures of the treatments' effects.
In specific aim 1, we will determine the critical shared components of neural circuitry affected by prolonged
exposure to select ARVs. We will generate mesoscopic global maps of neuronal activation in mice presented
with relevant cognitive challenges after exposure to ARVs. We will then subject the mapping datasets to our
stepwise selection pipeline to identify the critical brain regions and neural circuits altered by the treatments. In
specific aim 2, we will determine the components of neural circuitry in NOD-hIL-34 mice, a humanized animal
model of HIV-1 infection, that are affected by exposure to select ARVs in the context of infection. Finally, in
specific aim 3, we will validate and extend the conclusions of our in silico investigations: we will monitor neuronal
activity in the candidate regions in vivo on the single-cell and population levels; apply monosynaptic tracing to
determine whether ARV treatment induces long-term changes in neuronal connections; and use chemogenetics
to manipulate neuronal activity in the key components of the inferred circuitry. Our experiments will create a
circuitry map space for the action of ARVs in the context of HIV-1 infection, upon which other circuitry maps that
describe various behavioral states and responses to treatments can be projected and compared. Our results will
help to characterize cognitive impairments in HIV-1 infected individuals receiving ART and in those using ARVs
as PrEP, and will inform future therapeutic efforts to treat HIV-associated neurocognitive impairment.

Public health relevance
NARRATIVE Although medications that inhibit the spread of HIV are effective, many people who take these drugs for a long time experience problems with memory and other brain functions. We have recently developed a new way to study how the activated parts of the animal brain are connected into networks. We now plan to use this approach to investigate which brain regions in mice infected or not infected by HIV1 are affected by the anti-HIV drugs and how these regions are connected. By studying the changes in the brain networks of animals treated with these medications, we hope to gain a better understanding of the cognitive side effects of these drugs. This research could help us find ways to reduce or prevent these side effects in people which take these drugs as prophylaxis or in people living with HIV.